Neural, endocrine, and behavioral markers of psychosocial stress predicting drug use outcomes in human opioid addiction

PROJECT SUMMARY/ABSTRACT
Opioid use disorder (OUD) is a public health crisis in America. Even among those in treatment, long-term
adherence to medication is low, and relapse is the norm. A core trigger for relapse is the experience of stress,
often involving psychosocial or interpersonal challenges. Preclinical models of OUD show that stress impacts
neural, endocrine, and behavioral functioning, increasing one’s vulnerability for initiating and sustaining the
addictive behavior. Here, we aim to translate these preclinical findings to human OUD patients on medication-
assisted treatment (primary drug: heroin; stabilized on the same medication dose for 1-6 months). We will employ
two broad approaches for examining psychosocial stress in patients, one utilizing chronic markers (i.e., trait-like
behavioral and imaging phenotypes) and one utilizing acute markers (i.e., state-like reactivity to a laboratory
induction paradigm which tests the adaptive capacity of the stress system). These approaches are fully
complementary (orthogonal), in that the chronic markers depend on between-person differences while the acute
markers depend on within-person fluctuations from each participant’s baseline. The chronic psychosocial stress
markers, to be acquired on Day 1 of the study, include: (1) social-cognitive functioning (emotion recognition task),
(2) fMRI activation during a decision-making task that involves exposure to threatening and drug-related images,
and (3) gray matter volume assessed with structural MRI and voxel-based morphometry. The acute psychosocial
stress markers will be acquired on Day 2 of the study (two weeks after Day 1), during which participants undergo
an experimental stress induction via personalized imagery. The acute stress markers include: experimentally-
induced changes in craving, salivary cortisol (marker of HPA functioning), and salivary alpha amylase (marker
of sympathetic activation). For each of these two approaches, we will test for hypothesized differences between
OUD participants and matched healthy controls (HC), and then within OUD we will test for hypothesized
correlations of the stress variables with scores from the Cumulative Adversity Interview (CAI), a well-validated
measure of lifetime cumulative psychosocial stress. Finally, OUD participants will be followed for 8 months to
track relapse status and drug use, which we hypothesize will be prospectively predicted by our multimodal stress
markers. With this design, we will address our study aims of uncovering whether there are abnormalities in the
neural, endocrine, and behavioral correlates of stress in OUD versus HC; whether such abnormalities in OUD
are exacerbated by cumulative adversity; and whether stress and its biological mechanisms predict OUD relapse
trajectories. Our study will advance basic knowledge of stress biology in OUD, a research area that to date has
been profoundly understudied compared with other addictions. Such knowledge may inform new therapeutic
targets for medication development and psychosocial intervention to help combat the opioid epidemic.

Public health relevance
PROJECT NARRATIVE This project uses a multimodal, longitudinal approach to uncover the neurobiology of psychosocial stress in human opioid use disorder, with potential to yield novel biomarkers that can be used to identify individuals who are especially vulnerable to stress-related relapse. This will ensure the most efficient allocation of scare clinical resources, as well as provide key empirical support for developing new evidenced-based treatments that target and fortify stress circuitry in opioid use disorder, in service of addressing the opioid public health crisis.